Multi-Omics Analysis of Broadly Neutralizing Antibodies and Therapeutic Vaccination

SUMMARY
The goal of this P01 program is to define mechanisms of efficacy of broadly neutralizing antibodies (bNAbs) and
therapeutic vaccines for HIV-1 in a highly collaborative and multifaceted research program. Our overall
hypothesis is that immunologic strategies for HIV-1 cure delay viral rebound both by targeting the viral
reservoir and by increasing host antiviral immunity. We will evaluate mechanisms of therapeutic efficacy in
both humans and nonhuman primates (NHPs) using coordinated virologic, immunologic, and multi-omic
approaches with the goal of developing improved next generation HIV-1 cure strategies. We will apply cutting-
edge, high-throughput, multi-omic profiling platforms and integrate these data sets to generate a comprehensive
tissue landscape and regulatory network of the viral reservoir and host immune responses.
This program builds on our existing studies over the past several years in both humans and NHPs evaluating
the ability of bNAbs and therapeutic vaccines to delay viral rebound following discontinuation of antiretroviral
therapy (ART). We will first utilize existing samples from these studies to generate hypotheses regarding
correlates of delayed viral rebound. We will then perform new interventional studies in NHPs with spatial multi-
omic analyses in lymph nodes and gastrointestinal mucosal tissues to test hypotheses in order to define
mechanisms of reservoir targeting by bNAbs and therapeutic vaccines.
The significance of this program is the potential to define the biologic pathways that lead to delayed viral rebound
following ART discontinuation. An improved understanding of partially effective bNAbs and therapeutic vaccines
in humans and NHPs will lead to basic research advances that will allow the development of improved next
generation HIV-1 cure approaches. To accomplish the goals of this P01 program, we propose the following
Projects and Cores:
Project 1. Multi-Omics Correlates of Broadly Neutralizing Antibody Efficacy
Project 2. Multi-Omics Correlates of Therapeutic Vaccine Efficacy
Core A. Administrative Core
Core B. Multi-Omics Core
Core C. Computational Analysis Core
Core D. NHP Core

Public health relevance
Broadly neutralizing antibodies and therapeutic vaccines have demonstrated antiviral efficacy in HIV-1-infected humans and SIV/SHIV-infected rhesus macaques. However, the mechanisms underlying the efficacy of these interventions remain unknown. We propose to define mechanisms of efficacy of broadly neutralizing antibodies and therapeutic vaccines using a coordinated virologic, immunologic, and multi-omic approach with the goal of developing improved next generation HIV-1 cure strategies.